Blackfeet Community College Center for Culture as Medicine, Administrative Core

The overarching goal of the current Blackfeet NARCH application is to improve the mental and physical health
of the Blackfeet Nation by developing the Blackfeet Community College (BCC) Center for Culture as Medicine
(CCM). To realize this goal, the BCC-CCM must accomplish the center’s overall aims, which are to perform
interventions informed by our previous research to improve the physical and mental health of the Blackfeet
Nation, generate new results that will inform future interventions responsive to health concerns among the
Blackfeet Nation, and build the capacity of health equity research at BCC by developing the BCC-CCM. To
meet that goal and aims, each of the proposed projects of the BCC-CCM must meet its own specific aims. The
BCC-CCM Administrative Core (AC) will facilitate the accomplishment of individual projects’ aims, thereby
resulting in meeting the center’s overall goal. To this end, the AC’s specific aims are 1. accomplish the
overall aims of the BCC-CCM. The AC will assure that the individual projects are working together efficiently
by continually and carefully monitoring component activities and facilitating communications among them. As
such, the AC is responsible for allocating and overseeing all BCC-CCM resources; establishing and
maintaining partnerships, the Community Advisory Board, and the External Advisory Committee; and arranging
meetings and other activities essential to the success of the BCC-CCM. 2. maintain good relationships with
the Blackfeet community, be responsive to the research interests of the community, and disseminate
research results to the community. We have found that the Blackfeet community is very supportive of
biomedical research at BCC. This support has been best exemplified by the number of community members
participating in past research projects and their pride in research being conducted by Blackfeet people,
especially Blackfeet students. Each of the BCC-CCM projects is responsible for maintaining good
relationships/partnerships with the Blackfeet community, and it is the AC’s responsibility to assure that each
project does so. Recommendations and guidance, from either the BCC-CCM CAB or the individual projects’
CABs must be communicated to all center investigators and heeded. 3. build a sustainable BCC-CCM. The
most impactful result of NARCH funding would be the development of a sustainable Native research center. A
sustained center would have investigators who could improve the health of Blackfeet people and compete
successfully for external funding. We believe the previous BCC NARCH, by funding student and faculty
research development, positioned us to be able to propose the present application. By continuing to publish,
perform impactful interventions, generate published results that can act as preliminary data for future
proposals, and build research capacity, BCC-CCM will indeed become sustainable.

Public health relevance
The BCC-Center for Culture as Medicine Administrative Core will facilitate the accomplishment of the center’s specific aims as well as the aims of the center’s projects. Importantly, the Administrative Core will maintain the relationships with the Blackfeet Community and strive to develop a sustainable research center that will positively affect the mental health of the Blackfeet Nation.